Inflammatory and stress signaling networks in metabolic disease

DESCRIPTION (provided by applicant): In the past decade, it became clear that obesity is associated with chronic inflammation and this chronic inflammatory response plays an important role in metabolic deterioration. We have previously identified the role of c-Jun N-terminal kinase, JNK, as a key player integrating inflammatory and metabolic pathways in obesity as well as causing insulin resistance and type 2 diabetes. We also identified endoplasmic reticulum stress as a potential mechanism contributing to the activation of this pathway and causing insulin resistance and type 2 diabetes. Our recent studies exploring the mechanisms linking organelle function to activation of inflammatory and stress signaling cascades and insulin action, led us to a well-established pathogen sensing pathway mediated by the double-stranded RNA dependent protein kinase, PKR. We made exiting observations showing the marked activation of this kinase, which can act upstream of JNK and the eukaryotic initiation factor alpha (eIF2a) kinase, in obesity and insulin resistance. Our preliminary studies support that PKR is a required component of JNK activation in obesity and its absence results in marked protection against insulin resistance and type 2 diabetes. In this proposal, we will study the regulation and function of this kinase in obesity, insulin resistance, and type 2 diabetes, identify the cellular and molecular targets, characterize its role in linking the critical stress signaling pathways with insulin action, explore therapeutic potential through chemical intervention, and study mechanisms of action. A key question in the field is related to coordinated action of several inflammatory kinases during obesity and metabolic stress leading to insulin resistance and obesity. If our postulate is valid, PKR may provide a very critical mechanistic insight as an integrating molecule between inflammatory pathways and metabolic stimuli. For example, we observed that PKR is stimulated by lipids and critical for JNK activation and directly interacts and phosphorylates an important substrate of the insulin receptor, IRS-1. Others have suggested that PKR also interacts with IKK and eIF2a is a well-characterized substrate connecting PKR to ER function. We plan to pursue the protein complexes assembled around PKR at baseline and stress conditions, including lipid exposure, using proteomics approaches and investigate the molecular basis of these intermolecular interactions. Taken together with our observation supporting this application and published reports, we believe there will be opportunities to study the assembly of the key molecules in chronic inflammation and metabolic disease. Our long-term vision is to identify the components and characterize the function of a stress complex (or a metabolic inflammasome), which is potentially central to metabolic inflammation by integrating the key components of inflammatory signaling pathways and insulin action.

Public health relevance
Chronic metabolic disease, such as obesity, insulin resistance, and diabetes are among the most common diseases with adverse effects on quality of life worldwide. Despite their enormous burden on human life, the preventive and therapeutic opportunities are limited and there is ongoing need for new and more effective remedies. Our project aims to identify core mechanisms that give rise to these pathologies. Our focus is on the role of chronic inflammation in metabolic disease, with a focus on insulin resistance and diabetes. We postulate that we have discovered a novel mechanism that might explain the coordinate action of many inflammatory signaling pathways and how these mechanisms are integrated to disrupt metabolism. Most importantly, the mechanism that we plan to study is a reversible mechanism and hence could be the basis of future therapeutic approaches.